Artificial Intelligence Imaging Biomarkers of Longitudinal Cardiovascular Stress

ABSTRACT
Across every type of prediction model, applied to virtually any population, the single most substantial contributor
to incident cardiovascular disease (CVD) is older age. However, our understanding of why cardiovascular risk
dramatically rises with advancing age remains limited. Evidence to date suggests that CVD culminates from age-
related changes in cardiac structure and function that begin very early in adulthood and continue to develop on
a background of lifelong exposure to risk factors – contributing to an ‘age gap’ between biological age and
chronological age that grows over time. It logically follows that a person’s increasing burden of cardiovascular
risk should manifest as progressive cardiac abnormalities that can be tracked, analyzed, and identified over the
lifespan. Until recently, methods for assessing the cardiovascular ‘age gap’ have been limited. Recent advances
in artificial intelligence (AI), when applied to biomedical images, indicate that deep learning algorithms can both
offer precise measurements beyond human fidelity and also identify subtle traits in imaging that are unrecognized
by the human eye. In fact, our prior work applying AI to echocardiography as well as others applying AI to other
forms of medical imaging, have shown deep learning can not only reproduce standard measures of cardiac
structural and function but is also identify CVD risk features including chronologic age, biological sex, diabetes,
hypertension, and smoking. In effect, AI applied to echocardiography now offers the potential to capture an
aggregate measure of cardiac aging and, in turn, identify intervenable target for mitigating age-related CVD risk.
Thus, we hypothesize that AI methods applied to echocardiography can be used to not only predict biological
cardiovascular age but also (i) identify trajectories of accelerated versus delayed cardiovascular aging, (ii)
discern key contributors to accelerated cardiovascular aging phenotypes, and (iii) elucidate the excess age-
related risk for specific CVD outcomes that may be independent from any co-existing burden of risk factors or
subclinical cardiac disease. To test these hypotheses, we will leverage echocardiography images that are
acquired as a part of routine clinical care in addition to serial imaging frequently obtained in large cohort studies
of aging adults. Because healthcare cohorts are enriched for patients with accelerated aging trajectories, while
epidemiologic cohorts are enriched for individuals with delayed aging trajectories, we plan to analyze imaging
and outcomes data collected from both types of cohorts. Accordingly, our aims are to train and validate AI models
on predicting biological age from cardiac imaging and identify its component contributors to excess
cardiovascular risk in both the healthcare setting and in the community setting.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT The single most substantial contributor to incident cardiovascular disease is older age and, over the next decade, the number of adults age 65 and older will exceed 50 million in the United States. Cardiovascular disease culminates from age-related changes in cardiac structure and function that begin very early in adulthood and continue to develop on a background of lifelong exposure to risk factors. We will examine how deep learning applied to cardiovascular imaging can capture key features of cardiac aging that could represent intervenable targets for mitigating age-related cardiovascular risk.